Evaluating the association between mean arterial blood pressure through the first 24 hours after cardiac surgery and postoperative acute kidney injury

Approximately half a million patients undergo cardiac surgery in the United States each year. Acute kidney
injury (AKI) complicates 25% of cases, and is associated with increased hospital length of stay, cost,
progression to chronic kidney disease and death. Inadequate blood pressure during the early postoperative
period is a likely contributor to AKI after cardiac surgery that may be effectively addressed with a higher target
mean arterial pressure (MAP) during this period. Current practice typically targets a MAP ≥65 mmHg after
cardiac surgery but whether this is the optimal target pressure for minimizing kidney injury is unknown.
The long-term objective of our research is to minimize the incidence of AKI after adult cardiac surgery
through identification of an optimal postoperative target MAP in this setting. The objective of the proposed
cohort study is to harness existing minute-by-minute postoperative MAP data from patients undergoing cardiac
surgery to identify a postoperative MAP threshold beyond which the risk of AKI increases and, separately,
explore for evidence of association between early postoperative MAP and other non-renal harm that may also
need consideration in selecting the most appropriate target-MAP for testing in a clinical trial.
Our Specific Aims are to: 1a) Evaluate the association between time spent in each of multiple
absolute MAP range-bands (e.g., 65-69, 70-74 mmHg) through the first 24 hours(h) after cardiac surgery
and AKI; 1b) Evaluate the association between time spent in each of multiple discrete MAP range-
bands defined by the percent change from preoperative baseline MAP (e.g., -6 to -10%, -11 to -15%)
through the first 24h after cardiac surgery and AKI; 2a) Evaluate the association between time spent in
each of multiple absolute MAP range-bands through the first 24h after cardiac surgery and non-renal
adverse outcomes including each of delirium, stroke, blood transfusion and unplanned surgical re-
exploration; 2b) Evaluate the association between time spent in each of multiple discrete MAP range-
bands defined by percent change from preoperative baseline MAP through the first 24h after cardiac
surgery and the specified non-renal adverse outcomes. These aims will be achieved by regression
modelling of longitudinal MAP profiles created from minute-by-minute MAP data through 24h postoperatively in
patients undergoing cardiac surgery. Combined with validated outcome data and adjusted for key potentially
confounding covariates appropriate to each outcome, we will test the hypothesis that: Increased time spent
with MAP in each of the multiple discrete range-bands through 24h after surgery (relative to a reference MAP
range-band) is associated with an increased odds for AKI and, separately, other non-renal outcomes. Our
results will provide critical evidence to guide the data-driven selection of the most appropriate target MAP for a
future trial testing the effectiveness of this alternate target MAP to reduce AKI and improve patient outcome
after cardiac surgery.

Public health relevance
Project Narrative: Of the approximately half-million adult patients who undergo cardiac surgery every year in the United States, 25% suffer acute kidney injury (AKI) after surgery. This project will primarily characterize the association between early postoperative blood pressure and AKI, while also exploring for evidence of association between early postoperative blood pressure and other non-renal patient harm. Innovative use of minute-by-minute blood pressure data through 24 hours after cardiac surgery will precisely identify blood pressure thresholds and durations beyond which the risk of AKI and other patient harm increases, providing critical information to justify and inform the design of a randomized trial of an alternate postoperative target blood pressure to reduce AKI and improve patient outcome after cardiac surgery.